ELSI Biennial Congress

PROJECT SUMMARY
For nearly three decades, the National Human Genome Research Institute (NHGRI) has supported the
study of the ethical, legal and social implications (ELSI) of genetic and genomic research for individuals,
families and communities and supported the growth of a generation of ELSI researchers. ELSI research has
developed into a multidisciplinary field that spans the humanities, social sciences, natural sciences,
engineering, medicine and law. Despite these developments, opportunities for ELSI researchers to present
their research to their ELSI colleagues have been limited, as there is no regularly scheduled conference
dedicated to ELSI research. Current opportunities are limited to ad hoc sessions in related professional
meetings, and tend to be few in number and do not include the range of research or researchers
conducting ELSI studies nor offer the depth of exchange and dialogue that a dedicated meeting would
provide.
To address the need for a regularly scheduled ELSI Congress, we propose to organize biennial ELSI
Congresses in 2020, 2022, and 2024. Our multi-disciplinary team brings over two decades of experience in
leading ELSI funded research and training programs and engaging a broad range of stakeholders in ELSI
research and translational genomics. Guided by the principles of inclusion, diversity and access, the specific
aims of this proposal are:
1. To organize three biennial Congresses (2020, 2022, 2024) that highlight high-quality, high-impact ELSI
research.
2. To achieve diversity of perspectives and approaches represented in the Congresses towards the goal
of increasing the rigor and expanding the intellectual base of ELSI research.
3. To use feedback from Congress organizers and participants to develop improved approaches and
features with each subsequent meeting.

Public health relevance
NARRATIVE The goal of the biennial ELSI Congress is to provide a dedicated, regularly scheduled meeting for researchers focused on the ethical, legal and social implications of genetic and genomic research and its translation into clinical care.